The role of AMPK and CD36 in breast cancer metastasis

Background and Innovation: The mortality and morbidity from breast cancer are due to its metastatic
spread. Clinical data showed a strong correlation between the expression of fatty acids translocase CD36
and the progression of breast cancer and tumor-free survival. We found in mouse models of breast cancer
metastasis that high fat diet (HFD) increased metastasis and either cell autonomous deletion or systemic
deletion of CD36, which emulates drug therapy, inhibits HFD-induced metastasis. Since the systemic
deletion of CD36 does not exert any adverse consequences, the results suggest that it is a therapeutic
target for breast cancer metastasis. We also discovered a new paradigm and showed that CD36 is not an
unbiased transporter of fatty acids but enables the uptake of saturated fatty acids by increasing the uptake
of unsaturated fatty acids to prevent lipotoxicity. Finally, we found that the induction of CD36 expression is
dependent on the activation of AMPK. The role of AMPK in tumorigenesis is controversial. Although AMPK
inhibition was implicated in promoting tumorigenesis, we and others showed, that AMPK activation is
required for tumor cells survival during tumor formation and its inhibition impedes tumor growth. We found
that AMPK is also required for breast cancer metastasis in several mouse models of breast cancer
metastasis, and that expression of CD36, inhibition of oxidative stress, and the inhibition of the downstream
effector of AMPK, acetyl-CoA carboxylase (ACC) could recover metastasis inhibited by AMPK deletion. In
this grant application we will further delineate the mechanisms by which AMPK and CD36 are required for
metastasis. In the first part of the grant application, we will determine the time during tumor development
in which AMPK is required for metastasis; we will explore the roles of ACC1 and ACC2 downstream of
AMPK in mediating metastasis; and we will determine the effect of AMPK activation, which is considered
anti-tumorigenic, on breast cancer metastasis. In the second part of the grant application, we will delineate
the mechanisms by which CD36 is required for breast cancer metastasis downstream of AMPK and we
will explore the effect of systemic CD36 deletion on tumor microenvironment. We will employ patient
derived xenografts (PDXs) and patient derived organoids (PDOs) to determine the effect of AMPK
activation on tumor growth and metastasis as well as the effect of CD36 inhibition on tumor growth and
metastasis. In summary, will use human breast cancer cell lines and patients derived organoids and
orthotopic transplantation as well as genetically engineered mouse models for breast cancer metastasis
in these studies.
Significance and Impact to Veterans Healthcare: Breast cancer is the most frequently occurring cancer
in women. Military women are at increased risk of metastatic breast cancer. There is a gap in knowledge
whether breast cancer patients should be treated with AMPK activators or anti-CD36.
Path to translation/implementation: The proposed studies have a translational impact as they will
determine whether drug therapy that activates AMPK directly or indirectly could have worse outcomes with
respect to breast cancer metastasis, and whether targeting CD36 could inhibit breast cancer metastasis
particularly in obese patients.

Public health relevance
Studies suggest that veterans are at a higher risk of developing breast cancer than the rest of the population. The metastatic spread of breast cancer cells from the primary tumor to surrounding tissues and to distant organs remains the primary cause of breast cancer morbidity and mortality. Despite the deleterious consequences of metastasis, a robust understanding of how the process is initiated, the metabolic signatures and signaling components involved in regulating the same are still nebulous. During invasion, cancer cells show altered and decreased cell–matrix interaction and this interaction is further reduced in the circulation. An inevitable outcome of matrix detachment is reactive oxygen species (ROS) accumulation and enhanced anti-oxidant defenses permit cancer cells to survive as circulating tumor cells in vivo. Thus, understanding the mechanism by which metastatic cells combat ROS could lead to therapeutic strategies that eradicate breast cancer metastatic cells.